Plant-derived extracts regulate immunosuppressive myelopoiesis in Breast cancer patients

ABSTRACT
This supplement is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
22-054. Therapeutic strategies based on traditional, complementary, and alternative medicine (TCAM) have
emerged as a potential treatment option for cancer, especially in low- and middle-income countries (LMICs) with
limited access to advanced technologies. However, the impact of well-controlled TCAM-based treatments in the
modulation of protective anti-tumor immunity in cancer patients remains poorly defined. Expansion of myeloid-
derived suppressor cells (MDSC) in tumor-bearing hosts represents a primary mechanism to limit protective anti-
tumor T cell immunity and a major obstacle to the success of cancer immunotherapy. It is therefore imperative
to develop new effective therapeutic strategies to overcome the immune restricting effects induced by MDSC in
tumors. Our recent studies demonstrated that MDSC in tumors activate an integrated signaling network known
as the unfolded protein responses (UPR) as a reaction to the sustained and pronounced endoplasmic reticulum
(ER) stress induced by the precarious conditions of the tumor microenvironment (TME). Furthermore, conditional
deletion of the UPR-related PKR-like ER kinase (PERK) functionally reprogrammed tumor-MDSC into immune-
stimulatory cells that partially restore protective anti-tumor immunity. In the related R01, we postulate that the
accumulation of Bile Acids (BAs) in tumor-bearing hosts restricts the functional transformation of PERK-ablated
MDSC. However, the validation of the BAs and ER stress axis in MDSC in human populations remains unknown.
P2Et, a polyphenol-rich extract from plant Caesalpinia spinosa, promotes anti-tumor activities through activation
of protective immunity and direct anti-tumor effects, both reducing the frequency of intratumor MDSC. Although
P2Et induces anti-tumor actions in animal models, its effect in patient populations remains unknown. In this
supplement, we aim to intersect a funded Phase I/II clinical study testing the effect of P2Et in Breast cancer (BC)
patients receiving neoadjuvant chemotherapy in Colombia, South America, with R01-linked research testing the
effects of MDSC undergoing elevated ER stress activation and alterations in plasma BAs. We hypothesize that
patients receiving P2Et as part of their treatment regimen will show reduced numbers of ER-stressed MDSC and
lower levels of circulating BAs, which associate with positive therapeutic responses. We propose the following
Specific Aims: Aim 1. Evaluate the expansion of circulating MDSC and plasma BAs in stage II-III BC patients
undergoing treatment with P2Et plus neoadjuvant therapy. Aim 2. Determine whether alterations in circulating
MDSC and plasma BAs predict responses in stage II-III BC patients administered with P2Et. Proposed research
will advance the scope of the parent RO1 by potentially elucidating the effects of the ER stress and BAs axis in
MDSC from cancer patients, while enabling TCAM-based strategies in LMICs to drive protective immunity,
potentially overcoming a substantial obstacle for cancer immunotherapies.

Public health relevance
PROJECT NARRATIVE This supplement will integrate a Phase I/II Clinical Therapeutic strategy based on traditional, complementary, and alternative medicine (TCAM) being developed in a low- and middle-income country (LMIC, Colombia) with R01-related research elucidating metabolic mechanisms governing the function of myeloid-derived suppressor cells (MDSC) in tumors. Results are anticipated to advance the scope of the parent R01 by demonstrating the crosstalk between metabolic signals and MDSC in patient populations treated with a polyphenol-rich extract from a plant (Caesalpinia spinosa), while enabling immune modulating TCAM-based strategies in LMICs.